Developmental Core

The JHU CFAR Developmental Core (DC) supports novel research projects conducted by Early-stage Investigators (ESI), and it devises new and creative methods for training, mentoring and educating both ESI and established researchers. The principal purpose of the DC is to foster innovation through the funding of original investigator-initiated research studies by ESIs or faculty new to HIV research. The DC will be responsible for the following CFAR functions: a) solicitation, review, and funding of applications for Faculty Development Awards (FDAs)s and the small grant program, and final review of microgrants stemming from the SWGs; b) managing and overseeing the CFAR's training and mentoring programs, both individually and through our K club; c) identifying important recruitment opportunities and working with the Leadership Committee to develop recruitment support packages; d) self- evaluation; and e) establishment and maintenance of the DC components of the CFAR website.